Identifying and Addressing Opportunities in Primary Care to Improve Healthy Birth Intervals

ABSTRACT
Approximately 30% of pregnancies in the United States occur after a short interpregnancy interval (IPI) <18
months. Short IPI is associated with adverse maternal and infant outcomes, especially among women from
high-risk populations. Primary care offers an opportunity to engage and educate reproductive age patients
about birth spacing, provide preconception and contraceptive care between pregnancies (“interconception”
care) and coordinate their acute and chronic care needs. Groups with higher risks of adverse pregnancy
outcomes, such as low-income women, are more likely to receive their reproductive care from a primary care
provider (PCP) than an obstetrician-gynecologist. Three quarters of reproductive age women in the United
States have at least one physician visit each year, most commonly with their PCP; however, only 14% of office
visits involve preconception or contraceptive care. Many PCPs already feel task-saturated when delivering
primary care and face numerous barriers to providing high-quality interconception care. Although some
interventions appear to be effective, attempts to improve preconception/interconception care, within primary
care, have had limited success. We hypothesize that this may be due to inadequate design for sustainable
implementation into clinical workflows. This developmental study will therefore gather key stakeholders (e.g.
primary care clinicians, nurses, practice administrators and staff) and female reproductive age patients at three
diverse primary practices to take part in a failure modes effects and criticality analysis (FMECA). This risk
assessment engineering methodology will allow us to fully characterize and understand the failures/missed
opportunities in the systems and processes of primary care to deliver interconception care. We will then apply
an iterative user-centered design approach, building from existing interventions and from the FMECA results,
to create a novel intervention for integrating effective, patient-centered interconception care into primary care.
In future work, we intend to test this novel intervention using a type II hybrid implementation/effectiveness trial.

Public health relevance
NARRATIVE Approximately 30% of pregnancies in the U.S. occur after a short interval pregnancy (<18 months) and can lead to poor mother and infant outcomes, particularly among high-risk populations. Primary care settings offer an opportunity to provide preconception and contraceptive services to facilitate healthy birth spacing where reproductive age women seek most of their care, but currently, only 14% of office visits involve any counseling on these topics. This developmental study will use a failure modes effects and criticality analysis to comprehensively identify and characterize the missed opportunities to deliver effective interconception care in primary care settings and apply a user-centered design to create an interconception care delivery intervention that will be tested in a future hybrid implementation/effectiveness trial.